REVELANCE OF CHEMICALLY INDUCED HEMANGIOSARCOMAS IN B6C3FI MOUSE

It is hypothesized that epoxide intermediates play a role in the pathogenesis of hemangiosarcomas by causing genetic alterations in tumor suppressor genes and proto-oncogenes. Preliminary data has shown that chloroprene induced hemangiosarcomas have elevated p53 protein and specific point mutations have been detected in exon 5-8. Chemically induced hemangiosarcomas are being evaluated for specific genetic alterations in the P53 gene. Tumor suppressor gene and oncogene analysis will provide valuable information on the relationship between carcinogen exposure and DNA damage and the relevance to humans. It is hypothesized that epoxide intermediates play a role in the pathogenesis of hemangiosarcomas by causing genetic alterations in tumor suppressor genes and proto-oncogenes. Preliminary data has shown that chloroprene induced hemangiosarcomas have elevated p53 protein and specific point mutations have been detected in exon 5-8. Chemically induced hemangiosarcomas are being evaluated for specific genetic alterations in the P53 gene. Tumor suppressor gene and oncogene analysis will provide valuable information on the relationship between carcinogen exposure and DNA damage and the relevance to humans.